Caribbean Primate Research Center Program

PROJECT ABSTRACT:
The docking area at the CSBFS, which supports the P40 parent grant research activities, has been
damaged by recent hurricanes. Also, the SSFS is in urgent need to renovate the security and
internet systems. Thus, the major goal of this administrative supplement application is to acquire
a barch boat to access the island of Cayo Santiago by-passing the unusable dock, as well as to
provide a new equipment for security and internet service's enhancement a the SSFS.

Public health relevance
PROJECT SUMMARY: The major goal of this administrative supplement application for the Parent Grant P40 of the Caribbean Primate Research Center (CPRC) is to renovate, improve and expand the transportation system to the Cayo Santiago Biological Field Station, as well as the security and Wi- Fi systems at the Sabana Seca Field Station. The CPRC is one of the most important national resources for research program using indian- origin (IO) rhesus macaques with no history of admixture and with well-defined genetic and virological backgrounds. In the last five years it had provided 1,535 IO rhesus monkeys, supporting mainly NIH grants. The population management program for the CPRC has been designed to optimize the health and well-being of the monkeys, enhance the value of the colony for research, and provide healthy animals to the scientific community for a variety of studies. The Center is in the urgent need of renovating and improving the technology and sea transportation to support activities that have direct impact on animal wellbeing and research activities. This renovation will help the CPRC to achieve the research objectives within the original scope of the parent grant. Since 1938, the Center has supplied the scientific community with Indian origin rhesus macaques with known backgrounds and of the same genetic pool for use in studies of basic biology and diseases. The CPRC has vast experience in the establishment and maintenance of rhesus macaque breeding colonies. The animal care and use program of the CPRC is in compliance with the directives established by the Animal Welfare Act (AWA), PHS and other agencies. The Center is AAALAC fully- accredited.